Community Engagement Core

PROJECT SUMMARY – Community Engagement Core
New Mexico communities have historically borne an unequal burden of exposure to environmental
toxicants in the air, water and soil. Local communities experience high rates of poverty, limited access
to healthcare and generational trauma that intensify the impact of these environmental exposures.
Native American communities have led the way in sharing and addressing environmental health
concerns in partnerships with UNM researchers, based on culturally relevant, multi-directional
communication that advances environmental health science (EHS) responsiveness to the most urgent
health needs of local communities. The aims of the New Mexico Integrative Science Program
Incorporating Research in Environmental Sciences (NM-INSPIRES) Community Engagement Core
(CEC) are to 1) translate research and enhance environmental communication and environmental
health literacy using culturally-centered processes; 2) increase community-responsive environmental
health research through multi- directional communication with community stakeholders; and 3) enroll
community stakeholders and researchers in communication and cultural training to build capacity and
enhance community-academic partnerships. We will co-create and implement communication
dissemination plans for multi-modal outreach strategies, including print, digital, and social media
materials in plain language, visual arts for STEM-related environmental health messaging, community
events, and media advocacy to bridge the communication gap and ensure a well targeted, multi-
directional impactful flow of information meaningful to New Mexico communities. We will ensure NM-
INSPIRES’ responsiveness and relevance to community priorities through multi-directional interactions
among researchers and community stakeholders. We will communicate community concerns to
researchers and facilitate community-engaged research. We will increase enrollment of community
stakeholders and researchers in communication and cultural training to build capacity and enhance
community-academic EH partnerships. We will design, adapt, integrate and evaluate evidence-based
cultural and communication workshops for community and academic partners, policymakers, journalists
and clinicians to build a common framework of understanding and foster the strong relationships
needed for true multi-directional communications. NM-INSPIRES is uniquely positioned to lead EH
community engagement by drawing on our long-standing, culturally sensitive partnerships that are
respectful of the cultural diversity and historical trauma of local residents by integrating core values,
beliefs and practices into research programs. Our long-term goal is to secure an effective, ongoing
community-academic partnership that engages our diverse NM communities in environmental health
exposure research and translation, including environmental health literacy and risk prevention.